New Statistical Methods for Cox Regression with Measurement Errors in Cancer and Nutritional Epidemiology

Project Summary / Abstract
One of the greatest challenges in cancer and nutritional epidemiology is the uncertainty in covariate
measurements, which is a major source of bias in research aimed at elucidating causal relationships between
diet and cancer incidence and mortality. Dietary intake is usually estimated using a self-report food-frequency
questionnaire, and this dietary assessment is often subject to substantial measurement error. The issue of
exposure uncertainty lead to the potential for considerable bias in estimated health effects, masking our ability
to detect true associations. Right-censored survival outcomes are common in epidemiologic practice, and the
Cox regression model is typically used to model such outcomes. Regression calibration is a simple
measurement error adjustment method in Cox regression, and is often used in cancer and nutritional
epidemiology. However, when the degree of measurement error is large and the regression coefficient of the
error-prone covariate is large, regression calibration is unsatisfactory for bias correction due to exposure
uncertainty. We will develop an improved regression calibration method considering the degree of
measurement error and the coefficient of the error-prone covariate simultaneously in the calibration procedure.
The Expectation-Maximization (EM) algorithm has been remarkably applied for a wide variety of situations for
incomplete data problems. However, EM does not receive much attention to deal with measurement error
problems in survival data. We will develop a complete treatment of EM in main / validation studies to fill an
important gap in the literature. User-friendly publicly available software development will be a central feature
accompanying all new methods to be developed.

Public health relevance
Project Narrative One of the greatest challenges in cancer and nutritional epidemiology is the uncertainty in covariate measurements, which is a major source of bias in research aimed at elucidating causal relationships between dietary intake and cancer incidence and mortality. We will develop novel statistical methods for valid and efficient estimation of nutritional risks for cancer in survival analysis, resolving challenges arising in the study of nutrition and cancer due to uncertainty in the measurement of exposure, and apply them to studies arising in the Nurses’ Health Study and the Health Professionals Follow-Up Study. In addition, publicly available, user- friendly, and computationally efficient software will be developed to support the novel methods proposed in the project.